Clinical Translational Core

Clinical Translational Core Project Summary / Abstract
Major advances in our understanding of the genetic and environmental structure of neurodevelopmental
disorders present new opportunities to prevent or ameliorate intellectual and developmental disabilities (IDD).
The Clinical Translational Core (CTC) of the IDDRC@WUSTL will serve as an essential institutional resource
for supporting research that applies scientific discoveries on pathogenic mechanisms of IDD to benefit actual
patients through the development of high-impact personalized intervention that is guided by information
generated from natural history studies, biomarker development, and clinical trials. The CTC will serve as an
integrative scientific hub of the IDDRC@WUSTL linking patients along with their clinical and behavioral data to
clinical studies in the CTC and to research opportunities with the Model Systems Core and the Developmental
Neuroimaging Core. The Specific Aims of the CTC, designed to accelerate translational advances in IDD, are
as follows: 1) To provide investigators with the expertise, resources, and assessment services needed to conduct
comprehensive clinical, behavioral, and genomic characterization of human subjects for IDD-related research
and clinical trials through the Human Genomic and Phenotypic Characterization Unit (HGPCU) and Clinical Trials
Unit (CTU), and to leverage this activity with established, state-of-the-art genome technology services at WUSTL
to contribute to understanding of the pathogenicity and functional significance of variation in genes influencing
the developing human brain. 2) To strategically harness services and expertise of allied WUSTL facilities that
critically and cost-effectively complement the IDDRC@WUSTL scientific cores to contribute to a discovery
pipeline for higher-impact intervention and clinical trials for individuals affected by or at risk for IDD. Initial
implications-for-treatment of new discoveries in IDD pathogenesis are often first discovered through advances
in the Model Systems Core and made ready for translational applications utilizing CTC services. Similarly, brain
circuitry data from the Developmental Neuroimaging Core are assimilated with behavioral and genomic data
collected using CTC resources to identify early biomarker risk profiles and inform developmental timing of
intervention and prevention, 3) To promote bidirectional interchange between scientific activity in the discovery
of pathogenic mechanisms and the testing of novel approaches to IDD prevention and treatment in human
subjects and among populations at risk. This will occur in the context of a dynamic interface with the other two
scientific core facilities of the IDDRC@WUSTL (the Developmental Neuroimaging and Model Systems Cores),
facilitated by dedicated faculty liaisons whose roles are to cultivate cross-disciplinary science.